Agile Development of a Digital Exposure Treatment for Youth with Chronic Musculoskeletal Pain

Abstract
Chronic musculoskeletal (MSK) pain affects the lives of over a quarter of youth, with societal costs exceeding
$19.5 billion dollars in the U.S. each year. The impact of chronic MSK pain in adolescence is felt into adulthood
and is a documented risk for opioid misuse. There are a number of efficacious behavioral interventions for
adolescents with chronic pain, but many access-to-care barriers exist, highlighting the critical need to develop
digitally delivered behavioral interventions to drastically increase reach. Graded exposure is a theory-
driven, individually-tailored intervention for individuals with chronic pain targeting pain-related impairment by
exposing patients to previously feared and avoided activities. This project seeks to develop and evaluate the
feasibility and preliminary effectiveness of a digital exposure treatment (iGET Living) for adolescents with chronic
musculoskeletal (MSK) pain and their parents, utilizing a sequential replicated and randomized single-case
experimental design (SCED) and incorporating innovative technology for remote biomechanical assessment.
The central hypothesis is iGET Living will be acceptable and feasible for youth with chronic MSK pain and their
parents and will be effective at alleviating functional disability and pain-related distress. Agile research methods
will allow for a rapid, iterative development and evaluation of the intervention, yielding a clinically useful solution.
This proposal includes a comprehensive training plan under the guidance of mentors with expertise across study
aims. Dr. Harrison will obtain specialized training in 1) user-centered design and agile development of digital
interventions, 2) clinical research and trial execution, 3) intervention optimization, dissemination, and
implementation science, 4) innovative, remote assessment of biomechanical function, 5) advanced qualitative
and quantitative statistics, and 6) experiential learning in grant-writing. Research: Aim 1: In an iterative, user-
experience design process, Dr. Harrison and her team will develop iGET Living for adolescents with chronic
MSK pain and their parents. Data regarding comprehensiveness and acceptability will be collected via interviews
with patients and parents. Clinicians specialized in pediatric chronic pain will provide feedback on how providers
might integrate into practice, who they would refer, and potential barriers to utilization. Aim 2: Dr. Harrison will
evaluate preliminary feasibility and effectiveness of iGET Living to reduce pain-related distress and functional
disability utilizing SCED with multiple measures. Successful completion of these aims will provide the opportunity
to rapidly evaluate treatment effectiveness and inform iterative development of iGET Living to prepare
subsequent RCTs. The strong mentorship team, specialized career development training, and proposed
research plan will allow Dr. Harrison to gain the expertise needed to seek R-level funding and achieve her long-
term career goal of becoming an independent clinician-scientist with expertise in developing digital interventions
for youth with chronic pain and their parents.

Public health relevance
Project Narrative There is a critical need to develop digitally delivered behavioral interventions for adolescents with chronic pain to drastically increase the reach of evidence-based interventions around the country and worldwide. This proposal seeks to systematically develop and evaluate the feasibility and preliminary effectiveness of a digital exposure treatment for adolescents with chronic musculoskeletal pain, utilizing a sequential replicated and randomized single-case experimental design (SCED) and incorporating innovative technology for remote biomechanical and daily physical activity assessment. Agile research methods will allow for a rapid, iterative development and evaluation of the intervention which will be further evaluated in a pilot trial utilizing SCED, providing the opportunity to rapidly and pragmatically evaluate treatment effectiveness in small cohort— ultimately yielding a clinically useful, evidence-based digital solution.